Role of heat shock transcription factor HSF1 in tumorigenesis

Among human malignancies, primary liver tumors account for 9% of all cancer deaths worldwide and 12% in
developing countries. HCC accounts for up to 85% of liver cancers and is one of the leading lethal malignancies
worldwide. Chronic liver damage caused by viral infection (HBV and HCV), alcohol, non-­alcoholic fatty liver
disease (NAFLD)-­associated chronic inflammation, fibrosis, cirrhosis, or a combination of these factors
increases the risk for HCC. Notably, NAFLD, a hepatic manifestation of metabolic syndrome, affects nearly 25%
of the US population, and its incidence is rapidly increasing since obesity and metabolic syndrome are growing
epidemics worldwide. Although the risk factors are well defined, HCC is still an aggressive and difficult-­to-­treat
malignant disease with poor outcome and limited therapeutic options. In fact, major obstacles for effective
treatment of this cancer is that HCC is frequently resistant to chemotherapy and radiotherapy, and there is a
high frequency of tumor recurrence after curative surgical resection. Currently, there is a strong rationale for
immune intervention in HCC, but recent clinical trials have demonstrated that the benefits of immunotherapy are
relegated to a small fraction (~20%) of cancer patients, including these with HCC. This prompts the need for
greater understanding of the mechanisms underlying liver cancer cell plasticity and adaptation, as well as
developing novel therapeutic approaches to achieve more effective and selective cure of this disease.
Hsf1, as the master activator of the classical heat shock response and guardian of the proteome, has been
implicated in the pathogenesis of cancer. We have discovered that genetic inactivation of Hsf1 in pre-­clinical
mouse cancer models leads to remarkable inhibition of HCC development. On the basis of published and
preliminary studies we propose a novel pathogenic mechanism whereby Hsf1 activation promotes HCC
development by stimulating both the protein folding capacity of the cell and regulating anabolic metabolic
pathways, thus perpetuating chronic hepatic metabolic disease. Our recent research revealed that the Hsf1
transcriptional program enables malignant cells to escape immune surveillance. This may provide a new
approach to improve HCC treatment by improving the anti-­tumor immune capacity targeting Hsf1 activity. Our
experimental strategy entails the following three major approaches: 1. Determine the impact of hsf1 deletion on
liver cancer initiation and explore its therapeutic implications for advanced HCC, 2. Determine the metabolic and
epigenetic mechanisms by which Hsf1 ablation induces an effective anti-­tumor CD8+ T cell response, and 3.
Investigate the impact of Hsf1 deletion on improved CD8+ T cell-­based immunotherapy for HCC. In summary,
the long-­term translational goal of the project is to test the potential of Hsf1 targeting in human HCC. It will also
provide proof-­of-­concept for targeting Hsf1-­mediated metabolic programs for immunotherapeutic application of
liver cancer.

Public health relevance
Therapeutic exploitation of oncogene addiction has become a central aim of modern cancer therapy, but effective targeted therapies for aggressive cancer types including hepatocellular carcinoma (HCC) are lacking. In this proposal, a collaborating team of experts will investigate whether a valid approach for therapeutic interventions in HCC can be based on a strategy to inhibit supportive non- oncogene addiction pathways, interfering with tumor- promoting metabolic reprogramming and improving the predicted power of anti- tumor immunity through depletion of Hsf1. This research will provide the rationale to develop novel strategies to prevent, and perhaps treat, cancers, including HCC, that arise on the background of chronic hepatic injury due to impaired liver metabolism, protein homeostasis and suppression of anti- tumor immunity.